Administrative Core

ADMINISTRATIVE CORE - PROJECT SUMMARY
The ADMINISTRATIVE CORE will be led by Drs. Vinogradov and Redish, and guided by an External Advisory
Board and an Internal Advisory Board. It will be supported by an Administrative Coordinator and a Database
Management Coordinator. The Administrative Core will oversee all Center activities and progress. Namely, it
will foster collaboration through shared meetings, retreats, grants, publications, and student mentoring; provide
facilities, resources, services and professional skills to each Project; give oversight and guidance on data
management and harmonization; facilitate education and training; and support outreach and dissemination
efforts.